Cell-intrinsic mechanisms of presynaptic assembly

PI: Kurshan, Peri T.
PROJECT SUMMARY/ABSTRACT
Synapses are the fundamental information processing units in the brain and their dysfunction leads to
neurodevelopmental and neuropsychiatric disorders. Synapse development and organization is mediated in
part by a class of transmembrane proteins called synaptic cell-adhesion molecules (sCAMs), and mutations in
sCAM genes is highly associated with diseases such as autism, schizophrenia and intellectual disability,
among others. The dominant model for synapse formation suggests that it is initiated by the trans-synaptic
binding of sCAMs, however in vivo evidence for that model is lacking. Here we propose to uncover non-trans-
synaptic cell-intrinsic molecular programs for presynaptic assembly that mediate the localization, trafficking and
subcellular functions of sCAMs and other integral presynaptic proteins.
Our preliminary evidence suggests that the intracellular domains of the presynaptic sCAMs neurexin and
syg-2/nephrin are cell-autonomously required for presynaptic organization. Moreover, we find that the
localization of neurexin to the presynaptic active zone is mediated by intracellular interactions with active zone
scaffold proteins and kinesin motors. Finally, we have found that the dependence of sCAMs and other active
zone proteins on transport by kinesins depends on the stage of axonal outgrowth. Based on these findings, we
hypothesize that presynaptic assembly is mediated in large part by cell-intrinsic mechanisms. We propose to
pursue three Specific Aims to characterize the mechanisms that govern (1) the intracellular recruitment of
sCAMs, (2) the intracellular organization of proper synapse spacing by sCAM-mediated cytoskeletal
rearrangement, and (3) the delivery and reallocation of sCAMs and other active zone proteins by kinesin-
dependent and independent mechanisms at different stages of axonal outgrowth (Aim 3).
To investigate these hypotheses, we leverage the genetic tractability and stereotyped nervous system of
the nematode C. elegans, along with innovative imaging and genetic approaches. C. elegans has a long
history of revealing fundamental synaptic biology and our previous published results and preliminary data
position us well to take advantage of the power of this system. Collectively our proposed research will reveal
how cell-intrinsic mechanisms govern the function of sCAMs in synapse formation. These studies have the
potential to uncover the molecular mechanisms underlying neurodevelopmental disorders that result from
defects in sCAM function, and thus provide targets for the development of specific therapeutic interventions.

Public health relevance
PI: Kurshan, Peri T. Project Narrative Mutations in synaptic cell-adhesion molecules such as neurexins are highly associated with neurodevelopmental and neuropsychiatric disorders and often lead to defects in synapse formation, although the molecular mechanisms by which this occurs are still largely unknown. In this proposal, we seek to understand the cell-intrinsic mechanisms by which presynaptic cell-adhesion molecules including neurexin are localized to synapses and contribute to their maturation. As a result, this research will have the potential to reveal novel therapeutic approaches to target diseases associated with defects in this critical class of synaptic proteins.